Collaborative Cross Strains as Models of Systemic Autoimmunity

Inbred laboratory mouse strains have proven essential for research into systemic autoimmune diseases because
the inbred genotype provides a genetically uniform animal for experimental purposes. However, there is
restricted genetic heterogeneity among common laboratory strains primarily due to the origination from two
original Asian and European fancy mice. This has significantly reduced the diversity of common genetic variants
that are thought to contribute significantly to complex traits such as systemic autoimmunity. We propose that the
Collaborative Cross (CC) Recombinant Inbred (RI) panel is the best suited to model the range of phenotypes in
complex diseases because it is the only experimental mammalian resource with genome-wide genetic variation
randomized across a large, heterogeneous and reproducible population. Significantly, the CC RI panel adds the
genomes of three wild strains from three different continents that are not represented in the common inbred
strains. Consequently, the CC strains provide a powerful tool to model autoimmunity in a much more genetically
diverse panel than previously available. We therefore hypothesize that the much greater genetic heterogeneity
of CC strains, including contributions from wild-derived strains, will allow development of a wide range of
immunological and pathological features from apparent good health to systemic autoimmunity. Furthermore, we
posit that this will be amenable to genotyping and quantitative trait locus (QTL) analysis in a way not possible
with previous approaches. This is supported by our preliminary studies, which show that CC strains exhibit
differing levels of spontaneous anti-nuclear autoantibodies (ANA) and inflammatory biomarkers, allowing them
to be grouped into a number of phenotypes. Furthermore, the presence of wild-derived strains contributed to the
mapping of ANA positivity to loci on chromosomes 1 and 17. We believe that investigation of the profiles of
immune mediators, cellular inflammation, autoantibodies, and pathology in the CC RI panel will lead to the
identification of a more diverse spectrum of autoimmune phenotypes than currently available. Additionally, we
argue that analysis of the different autoimmune phenotypes among CC RI strains will enhance our ability to
identify specific genes and molecular and cellular pathways that discriminate steps in the progression from
apparent good health, to sub-clinical inflammation and/or autoimmunity, to systemic autoimmune disease. We
will address this in two aims. Specific Aim 1: Development of systemic autoimmunity in CC RI strains, and
Specific Aim 2: Genetic mapping of systemic autoimmunity in CC RI mice.
Successful completion of these studies should result in identifying new strains of mice to study the progression
of autoimmunity from apparent good health to systemic disease, a better understanding of the genetics,
biomarkers, and pathogenesis of systemic autoimmunity, and identification of potential therapeutic targets.

Public health relevance
Animal models have provided great insight into human disease including autoimmunity, however most animal model lack the genetic diversity of human populations. We propose that the Collaborative Cross (CC) mouse strains will improve our ability to study the genetics of autoimmunity. We believe that use of the CC strains will allow us to determine those genes that regulate the molecular and cellular pathways that lead to autoimmune disease.